Inhalable Extracellular Vesicles Engineering for Lung Cancer Treatment

PROJECT SUMMARY
Lung carcinoma is the leading cause of global cancer incidence and mortality, characterized by one of the
lowest five-year survival rates. My overarching goal is to pioneer potent precision therapeutics for lung
cancer treatment, focusing on the design of novel delivery platforms and the exploration of pathological
mechanisms to identify molecular targets for disease prevention and treatment. A primary focus of my
research is interleukin-12 (IL12), a next-generation anti-cancer agent recognized for its robust tumor
suppressive properties. However, its clinical application is limited by significant off-target toxicity. The
current standard of intratumoral injection is not feasible for treating lung cancer due to accessibility issues.
In response, I have developed inhaled IL12 mRNA-loaded exosomes, achieving significant localized delivery
and enhanced immunogenicity. Yet, challenges remain with the encapsulation efficiency of electroporation
and the high costs associated with large-scale mRNA production. Aim 1 is to enhance IL12-induced lung
cancer immunotherapy by engineering the exosome biogenesis process. This involves designing exosome-
based RNA delivery platforms that enable high mRNA encapsulation, simplify scalability, and reduce costs.
Exosomes also play a crucial role in mediating intercellular and inter-tissue communication, especially in
pathological modulation. Emerging evidence suggests that the coexistence of lung cancer and cardiac
diseases severely worsens the prognoses of lung cancer patients. Given the prevalent incidence of cardiac
fibrosis, I hypothesize (Aim 2) that this condition may exacerbate lung cancer, a hypothesis supported by
my preliminary data. An additional hypothesis explores the potential mechanism, hitherto unexplored, that
may be mediated by cardiac fibroblast-derived exosomes. These exosomes could regulate lung tumor
growth by transmitting complex biological messages. AIM 3 is dedicated to advancing precision therapy for
lung cancer patients suffering from cardiac disorders. This will be accomplished by engineering exosomes
endogenously loaded with therapeutic RNAs, a platform developed in Aim 1, through clarified mechanisms
of heart-lung interplays in Aim 2. The K99/R00 phase represents a crucial period for honing my scientific
expertise and transitioning to independence, where I will advance therapeutic systems and elucidate
mechanisms to provide precision medicine for cancer patients with a high clinical association, such as those
with increasing cardiac threats.

Public health relevance
PROJECT NARRATIVE This proposal aims to engineer the exosome biogenesis process to develop innovative exosome platforms tailored for interleukin-12 (IL12) mRNA delivery, enhancing lung cancer immunotherapy. Given the rising prevalence of concurrent lung cancer and cardiac fibrosis, this research will also elucidate how cardiac fibrosis accelerates lung cancer progression via exosome-mediated mechanisms. Subsequently, the development of precision therapeutics will expand therapeutic options for patients facing compounded risks from cardiac diseases, offering targeted, effective treatments for this group.